Epigenetic Regulation of KSHV Latency

PROJECT SUMMARY
Kaposi’s sarcoma-associated herpesvirus (KSHV) causes several AIDS-defining malignancies
including Kaposi’s sarcoma (KS), the most common oral cancer affecting people with HIV.
Persistence of KSHV cancers is rooted in the ability of the virus to establish life-long latency, a
dormancy-like phase where no virions are produced, and gene transcription is restricted to the
latency genes to drive tumor cell survival and proliferation. In latency, KSHV represses lytic genes
that are typically used for viral replication and propagation to evade immune surveillance. Majority of
primary tumor cells are latently infected with only <5% of cells supporting lytic replication which is
necessary for dissemination. Thus, the balance of latency and lytic transcriptional programs is crucial
to KSHV malignancies. Our long-term goal is to understand mechanisms underlying the control of the
latency and lytic transcriptional programs. We and others have shown that the latency-lytic balance is
coordinated by the organization of the viral genome. However, it remains unknown how these higher
order structures are initially formed or how they are maintained after latency is established. Using a
CRISPR/CasRx screen tiling the KSHV genome, we recently discovered that a novel long non-coding
RNA (lncRNA) from the origin of lytic replication (OriLytL) is critical for viral latency (OriLytL-lat RNA).
This was surprising because the OriLytL is only known to function during lytic replication and not
during latency. Based on our preliminary data and strategic positioning of this latent lncRNA at the
origin of lytic replication, the central hypothesis of this proposal is the OriLytL-lat RNA mediates the
latent-lytic balance by driving chromatin remodeling and genome localization. Specifically, we will
study how this lncRNA organizes the viral chromatin structure before and after establishing latency. In
addition, we will investigate how this directs the spatial localization of the latent chromatin which has
now emerged to be a major factor of gene regulation. Together, these Aims will define mechanisms of
latency establishment and maintenance which are key to KSHV malignancies.

Public health relevance
PROJECT NARRATIVE The tight control of viral latency by the Kaposi’s sarcoma-associated herpesvirus (KSHV) is critical for tumor cells in several AIDS-defining malignancies including Kaposi’s sarcoma (KS), the most common oral cancer affecting people with HIV. In this study, we aim to understand the molecular mechanisms underlying the control of viral latency. These can be leveraged to develop treatments for KSHV cancers including oral KS in people with HIV.